Administrative Core

Administrative Core
Project Summary/Abstract
The Administrative Core will be located on the 4th Floor of Emory Children's Center in the Aflac Cancer Center
and Blood Disorders Center and will serve as the focal point for the administration of the FVIII Centers in the
achievement of the overall objectives of the program. The Administrative Core will provide an organizational
structure designed to provide support to the participating Centers, including the Principle Investigators, Project
Leaders, Skills Development Core Directors, and Trainees in order to maximize our collective abilities to advance
the understanding of the immune response to FVIII. The Administrative Core has several specific functions: (1)
To provide leadership to, and promote collaboration among, the Steering Committee, the External Review Panel
and the overall NHLBI FVIII Centers program; (2) To execute administrative functions including fiscal oversight,
budget management, coordination of communication (including conference calls, face to face meetings and
cross training of new investigators) between member Centers, and documentation of scientific and administrative
meetings; (3) To plan the annual FVIII Centers Scientific Symposium and to assist the NHLBI in planning the
Annual Centers Meeting; (4) To implement quality control measures to ensure scientific rigor and compliance
with all governmental, NHLBI, and local regulations and requirements (5) To facilitate active interchange between
all components, disseminate new information, and to foster collaboration between the local participating
institutions, the Administrative Coordinating Center and the NHLBI Program Director; (6) To facilitate the
members of the skills development cores connecting with project leaders at other Centers for collaboration and
training; and (7) To develop and maintain a website for the Centers to facilitate these interactions.